Molecular Mechanisms of Exercise Benefits to Insulin Resistant People

PROJECT SUMMARY
This renewal application continues to focus on older people with insulin resistance (IR) and aims to understand
the mechanisms of exercise benefits. The original grant focused on the mechanisms of resistance exercise
training (RT) related enhancement of peripheral (muscle) insulin sensitivity (IS) and muscle hypertrophy. The
premise of the current proposal is built on substantial preliminary data obtained with a supplement to our current
grant which was focused on the effect of RT on brain metabolism and cognition. We will address the neuronal
benefits of six months of either high-intensity aerobic interval training (HIIT) or RT in 60–85-year-old people with
IR compared to sedentary controls (n=24 per group). We hypothesize that enhancement of IS in response to six
months of HIIT or RT will improve cognition, measured by NIH Toolbox, concurrent to enhanced brain regional
connectivity, measured by resting-state functional MRI, and greater glucose uptake in brain regions rich in insulin
receptors, measured by PET scanning (F-18 FDG). We also will determine whether HIIT and RT increase cortical
and hippocampal volumes measured by volumetric MRI. Although exercise benefits in central neuronal
regulation are postulated, based mostly on pre-clinical experimental data, the benefits of exercise training on
brain metabolism and cognition remains incompletely defined in humans. Furthermore, in addition to our
postulation that exercise training enhances neuronal connections within the brain, we also propose that exercise
can enhance neuronal connection between the brain and skeletal muscle. We will utilize transcranial magnetic
stimulation combined with electromyography (TMS-EMG) to test a hypothesis that RT and HIIT increase
neuronal connections from the central nervous system to muscle, as indicated by lower threshold of cortical
stimulation needed to activate muscle, prior to structural and morphological changes accompanying long-term
exercise training. We will compare TMS-EMG data at baseline, 2 weeks, 3 months, and 6 months after the
initiation of exercise training with changes in muscle mass, histology, and metabolites. The results from these
studies will determine if there are central neural adaptations to exercise training that drive muscle mass and
strength changes. To ensure the successful completion of the study, we have assembled a group of highly
experienced investigators with strong collaborative track records. The results from the proposed studies are
likely to substantially advance our understanding of exercise benefits to neuronal and cognitive function in people
with IR, who are at 2- to 4-fold greater risk for developing dementia compared to people without IR. We submit
that these results can potentially form the basis of targeted exercise therapies and lay the groundwork for
developing novel therapeutic approaches benefitting people who are unable to perform exercise training.

Public health relevance
PROJECT NARRATIVE This proposal investigates whether enhancement in insulin action by six months of either high-intensity aerobic and resistance exercise training improves various measures of brain functions and brain-muscle connections, potentially explaining the improvement of cognition in people with insulin resistance. Insulin resistance is a condition in diabetes, obesity, and aging where insulin action is low and is associated with significantly higher prevalence of Alzheimer’s disease and other dementias. These studies based on high-technology brain imaging and functional measurements in combination with cognitive function are anticipated to reveal novel insights on how exercise training prevents dementia in people with insulin resistance.